Residential Greenness, Airway Microbiome,and Incident Childhood Asthma

The major challenges for developing primary prevention strategies for childhood asthma
are the early identification of modifiable risk factors (e.g., environmental factors,
microbiome) and the heterogeneity of asthma. Our group has applied integrated omics
approaches to infancy data, and identified endotypes at high risk for asthma. No study
has examined the integrated role of residential greenness, airway microbiome (both
composition and functional capacity), and host response during infancy in the
development of childhood asthma and its phenotypes. Our central hypothesis is that an
interrelation between the residential, airway microbiome, and the host will shape earlylife
immunity and contribute to the development of asthma and its phenotypes. We will
leverage airway samples and comprehensive environmental, clinical, and omics data
from three multicenter prospective cohorts. The 30th Multicenter Airway Research
Collaboration Finland (MARC-30 Finland) is an ongoing multicenter cohort study of 408
infants with severe bronchiolitis. The MARC-35 (U01 AI087881) is an ongoing
multicenter cohort study of 919 infants with severe bronchiolitis. The MARC-43
(UG3/UH3 OD023253) is an ongoing multicenter cohort study of 599 healthy infants.
The present R01 project would extend these well-phenotyped cohorts by generating the
residential greenness indices (Normalized Difference Vegetation Index and Green
Chlorophyll Index), sequencing airway metagenome and then examining their relations
to the development of asthma and its phenotypes by age 6-7 years. In Aim 1, we will
identify the integrated role of residential greenness and airway metagenome on
developing asthma (and its phenotypes) in severe bronchiolitis infants (MARC-30
Finland and MARC-35). In Aim 2, we will identify the integrated role of residential
greenness, airway metagenome, and host genome, on developing asthma (and its
phenotypes) in severe bronchiolitis infants (MARC-35 only). In Aim 3, to examine the
reproducibility and generalizability of findings from Aims 1-2, we will identify the
integrated role of residential greenness, airway metagenome, and host genome, on
developing asthma (and its phenotypes) in healthy infants (MARC-43 only). The
environmental (i.e., residential greenness and air pollution) and metagenome data
generated by this R01 project—along with parallel multi-omics (e.g., genome, DNA
methylome, transcriptome, metabolome) and immunological data available—offer an
unprecedented opportunity to develop data-driven mechanistic models for childhood
asthma and highlight preventive strategies based on the modifiable risk factors.

Public health relevance
Asthma is a major public health problem that affects 7 million children and 20 million adults in the U.S, and recent evidence indicates that the environmental factors and community of microbes that live in the airway can affect the immune system and risk for developing asthma. In three ongoing cohorts of U.S. and Finnish children, we will study residential greenness in infancy—in conjunction with airway microbiome and host genome data—to learn the role of these factors in the development of childhood asthma (and its different types). This research will not only contribute to our knowledge of how the residential greenness and microbial community interact to shape asthma risk, but also offer innovative approaches for the primary prevention of childhood asthma.